DESIGN AND SYNTHESIS OF IMMUNOMODULATORS AND VACCINE CONSTRUCTS

These studies are aimed at developing an effective immunotherapeutic vaccine for treating HIV-infected, immunocompromised individuals. As a model for such patients, Drs. B. Golding, H. Golding and D. E. Scott and their staff (CBER, FDA) have employed MHC class II deficient (“knockout”) mice (II-/- mice), since these mice have low CD4+ T cell numbers and are susceptible to opportunistic infections. We provided these investigators with conjugates of a synthetic peptide from the V3- loop structure of HIV-1 (MN). The conjugate carriers were heat-killed bacteria from Brucella abortus (BA). When injected into normal (WT) and II-/- mice, V3-BA induced high levels of cytokines, IL-12, IFNgamma (associated with a favorable Th1 type responses), and IL-10 mRNA. In both WT and II-/- mice, V3-BA but not V3-KLH developed serum anti-V3 antibodies of IgA and predominantly Ig2a, Ig2b and Ig3 isotypes. Sera from both WT and II-/- mice inhibited syncytia development at titers similar to those observed from a non-progressing HIV-1-infected subject. Thus, V3-BA induced potentially therapeutic antibodies in these immunodeficient mice and a cytokine profile that supports a good cellular immunity.We have designed and prepared a number of antibody- dextran conjugates that have been employed by Dr. Patricia Mongini at NY University in experiments aimed at exploring how the manner of presentation of an antigen at the B-cell surface affects activation thresholds and the cellular and biochemical events that follow activation of the resting, mature B cells. Co-culturing human tonsilar B cells with anti-IgM-dextran conjugates (surrogates for type II T- cell-independent antigen) resulted in both membrane IgM (mIgM)- triggered S/G2/M entry and apoptosis. Although high ligand valency (number of IgMs per dextran molecule) could compensate for low single- site affinity in triggering apoptosis, the effect was most pronounced when both factors were high. A protracted period of recurrent mIgM signaling events may influence whether apoptosis or cell cycle progression is the functional outcome of B cell encounter with multivalent antigen. In Dr. Mongini’s studies with a human B lymphoma (Ramos) cell line, evidence was gained for an upper (in addition to a lower) affinity threshold for anti-IgM-induced apoptosis above which increases in affinity were associated with diminished apoptosis. - immunomodulators, Th1 response, conjugate vaccines, B-cell activation, Brucella abortus, B-cell apoptosis, therapeutic vaccines